Multiomics and Antiretroviral Drug Exposure for assessing Metabolic Effects (MADE-FOR-ME)

Abstract
Over 38 million people across the world live with HIV. Although antiretroviral therapy (ART) has suppressed HIV
plasma viremia, the persistent inflammation in people living with HIV (PLWH) places them at two-fold greater
risk of developing metabolic diseases, including cardiovascular disease (CVD). CVD is biochemically associated
with predictive inflammatory metabolic biomarkers, such as apolipoprotein A1 (ApoA1), saturated fatty acids
(SAFAs), and ceramides. In numerous HIV clinical cohort studies, the excess CVD risk has been documented.
Systemic inflammation is an important factor in the pathogenesis of CVD. However, traditional CVD risk
assessments do not include direct cardiometabolic measurements of inflammation, nor are unique aspects of
inflammatory processes in PLWH considered. While the biochemical factors leading to inflammation and CVD
are multifactorial, antiretrovirals (ARVs) are a unique factor. ARV exposure induces changes in the functional
cellular transcriptomic and metabolomic profiles and increases inflammatory cytokines; these changes promote
CVD in PLWH. Therefore, the net influence on the cardiometabolic risk must be clarified to provide more targeted
CVD risk factor modification among PLWH. To address this knowledge gap, we will conduct the Multiomics and
Antiretroviral Drug Exposure for assessing Metabolic Effects (MADE-FOR-ME) study using stored specimens
from the Multicenter AIDS Cohort Study/Women Interagency HIV Study Combined Cohort Study (MWCCS) to
quantify ARV exposure and CVD inflammatory biomarkers. With these specimens, we will quantify ARV
exposure and perform experimental multiomics analyses to understand the molecular mechanisms underlying
the development of CVD. We will apply principal component analyses, Bayesian estimation methods, and
mediation analyses to understand the molecular mechanisms underlying the development of CVD, particularly
among different demographic groups living with HIV. We will make exposure-response relationships among
different populations such that we can stratify the risk and have population-specific biomarkers and/or
understand the limitations from more established biomarkers of interest. These are uniquely 21st century
clinical problems that require 21st century methodologies. Our project will likewise contribute to the fields
of drug development, computational biology, and systems physiology. By expanding into these areas,
we will synergistically impact and transform research studying HIV-associated comorbidities. We anticipate
discovering unique and potential drug targets and biomarkers to utilize for more precise monitoring of HIV-
associated CVD. With this committed multidisciplinary team, we will identify the effects of ARV exposure on
metabolic homeostasis and on inflammatory profiles and pioneer a new era of personalized medicine in
HIV/AIDS research with antiretroviral pharmacometabolomics.

Public health relevance
Project Narrative Over 38 million people in the world live with HIV and are at greater risk of developing cardiovascular diseases, even when receiving treatment for HIV. Because people living with HIV receive medications that affect the body’s metabolism towards developing cardiovascular diseases, we will use state-of-the-art methodologies to determine the relationship between exposure from these drugs and important metabolism markers. We will identify the effects of drug exposure and pioneer a new area of HIV/AIDS research and more reliably predict the development of cardiovascular diseases for those living with HIV.